Upstate New York Immunology Conference

SUMMARY
In an effort to provide a forum for immunologists (investigators and trainees) from the Upstate New York area
and surrounding regions to present and discuss their research and build collaborations, the Upstate New York
Immunology Conference was initiated in 1998 and initially included 53 participants from 3 institutions. This annual
meeting has now grown to include 11 institutions with current attendance of approximately 100 participants per
year. The specific objectives are: 1) to provide a forum for members of the regional immunology community to
present their work, exchange ideas, and develop collaborations; 2) to give students and postdoctoral fellows an
opportunity to meet distinguished scientific leaders in the field, as well as other trainees and PIs from area
institutions; 3) to give students and postdoctoral fellows an opportunity to present their work in a meeting format,
and obtain appropriate feedback on their projects; and 4) to increase local, national, and international awareness
of immunology research being conducted in the region. The meeting also addresses career issues through
workshops organized by the keynote speakers. The next meeting will be held October 16-19, 2023, at The
Otesaga Resort Hotel, Cooperstown, NY. It is anticipated that there will be approximately 100 participants from
Albany Medical College, the New York State Department of Health Wadsworth Center, SUNY Upstate Medical
University, the University of Rochester, Cornell University, Roswell Park Comprehensive Cancer Center, the
University at Buffalo, the University of Vermont, McGill University, The Ohio State University, and the Geisel
School of Medicine at Dartmouth. As in previous meetings, we will present 20 Young Investigator Awards based
upon outstanding abstracts selected by our Organizing Committee and Scientific Advisory Board members from
each of our 11 sponsoring institutions. All those wishing to attend will be accommodated within The Otesaga
Resort Hotel’s 300 rooms and extensive conference facilities.

Public health relevance
PROJECT NARRATIVE The annual Upstate New York Immunology Conference, currently in its 25th year, provides a forum for immunologists (faculty and trainees) from the Upstate New York area and surrounding regions to present and discuss their research and build collaborations.